GPR55 receptor signaling in binge alcohol drinking behavior

Project Summary
Alcohol abuse, particularly binge alcohol (ethanol) drinking, is a major public health concern. Recent
studies have revealed a high prevalence of binge drinking in adolescence and young adults. Like most
drugs of abuse, ethanol use is usually initiated in adolescence leading to short-term as well as long-term
negative health consequences, including increased risk for the development of alcohol use disorder (AUD).
Although significant advances have been made in understanding the neurobiology of AUD, the effect of
binge drinking on the brain and neuronal mechanisms contributing to the behavioral deficits are not yet
clearly understood. Recent studies have suggested that an orphan G-protein-coupled receptor 55 (GPR55)
signaling plays an important role in health and diseases. However, the role of GPR55 signaling in binge
alcohol drinking is currently unknown. The proposed research is focused on understanding the effects of binge
alcohol drinking in both adolescence and young adulthood on brain GPR55 signaling, and assess if the drugs
targeted to GPR55 regulate binge ethanol drinking using a C57BL/6J mouse model. This study will provide
further insight into neuronal mechanism of binge alcohol drinking, and the findings would assist in the
development of effective therapeutic interventions for AUD.

Public health relevance
Project Narrative Binge alcohol drinking has become a major health and societal problem. This study is focused on understanding the effects of binge alcohol drinking on brain GPR55 signaling in adolescence and young adulthood using a mouse model. This study further evaluates if drugs targeted to this signaling system have therapeutic potential for the treatment of chronic binge alcohol drinking.